ULTRASTRUCTURE AND CYTOCHEMISTRY OF SECRETORY CELLS

Basic mechanisms of the secretory process are studied in cells of the rat pancreas, salivary and lacrimal glands. Techniques utilized include light and electron microscopy, enzyme- and immunocytochemistry, radioautography, and biochemistry. Major areas of investigation are: (1) localizing of secretory and cellular proteins in developing and adult salivary glands using fluorescent and colloidal gold immunolabeling procedures; (2) experimental pathology and lysosome function in salivary glands; (3) structure and permeability properties of junctional complexes in rat salivary glands; and (4) the role of salivary duct cells in protein reabsorption.